Retail Food Safety Regulatory Association Collaboration

AFDO Application for RFA-FD-22-008 - Retail Food Safety Regulatory Association
Collaboration
PROJECT SUMMARY/ABSTRACT
The origin of this cooperative agreement announcement is from the development of the Retail
Food Safety Association Collaborative (Collaborative). The Collaborative was formed in 2019
after a series of discussions among the retail food regulatory associations Association of Food
and Drug Officials (AFDO), Conference for Food Protection (CFP), National Association of County
and City Health Officials (NACCHO), National Environmental Health Association (NEHA), FDA,
and the Centers for Disease Control and Prevention (CDC) about the need to have a collaborative
approach toward retail food safety to fully leverage each organization working in this space to
maximize the effectiveness.
Over the last two years, the Collaborative began many foundational activities that were
designed to assist retail food regulatory programs and industry in a number of areas: reducing
foodborne illness by implementing effective intervention strategies designed to reduce the
occurrence of foodborne illness risk factors; implementing and achieving full conformance with
the VNRFRPS; promoting use of risk-based inspection methods to effectively identify the
occurrence of foodborne illness risk factors, conduct root cause analysis, assess gaps in
industry active managerial control (AMC), and promote regulatory compliance; promoting
adoption of the most recent version of the FDA Food Code; effectively responding to foodborne
illness outbreaks; and responding to emerging food safety trends. The program is also intended
to encourage the research, development, and implementation of industry food safety
management systems and the prerequisite food safety culture necessary to achieve AMC of
foodborne illness risk factors.
Under this cooperative agreement, Collaborative members intend to build on these foundational
activities through continued sharing of individual accomplishments. Each member has identified
activities that individually, and collaboratively we will continue to gain better understanding of
the retail food safety state regulatory program environment, reduce the occurrence of retail
foodborne illness risk factors, and improve communications and availability of resources for
state, local, territorial, and tribal food safety programs.
AFDO’s major proposed projects under this cooperative agreement include:
 Gaining a better understanding of the retail food safety state regulatory program
environment through continuing surveys and interviews in targeted areas.
 Reducing the occurrence of retail foodborne illness risk factors by:
o Identification of foodborne illness interventions used at the state level,
categorizing, and evaluating the interventions for effectiveness
o Addressing identified barriers to adoption of recent version of the Food Code
o Promote and assess implementation of risk-based inspections
o Develop and promote strategies to improve active managerial control and food
safety culture in retail foods through owner, operator, and manager training
o Collating multi-state inspectional data and analyzing for trends among brands and
between states; and
o Improve response to retail foodborne illness outbreaks including Illness mitigation
through better coordination of tools, environmental sampling training, and
promotion of the National Environmental Assessment System (NEARS).
 Improve communications and availability of resources for state, local, territorial, and tribal
food safety programs.

Public health relevance
AFDO Application for RFA-FD-22-008 - Retail Food Safety Regulatory Association Collaboration PROJECT NARRATIVE The Association of Food and Drug Officials proposes to build on the foundational work started in the original cooperative agreement and to collaboratively work with the other associations awarded in this new cooperative agreement to further advance retail food initiatives to improve retail food safety, identify opportunities to reduce the occurrence of foodborne illness risk factors, and improve foodborne outbreak investigation. The highlights of our plans for this cooperative agreement are outlined here but described in detail in the Research Strategy. AFDO will conduct another series of state retail food safety interviews and will include specific questions about key criteria for risk-based inspections and how they have been implemented within each state. We will use the information gathered to develop some key measurements and comparability among the states. We will add data to the Data Analytics project including data from additional jurisdictions and years of data, completing further analysis. Focus will be on analysis of key areas related to foodborne illness risk factors and the frequency of “not observed” in these areas. Further, we anticipate comparing the inspection results with the frequency of foodborne illness risk factor violations and type of certified food protection manager training required by the state. The state surveys will also include questions about barriers to Food Code adoptions and what tools could be helpful for state programs to complete adoptions of more recent Food Codes including key provisions. We will create a webinar on completing regulatory adoptions, which was cited as one of the key barriers to Food Code adoption. We will also maintain the interactive maps developed during the initial cooperative agreement, including changes to contact information. AFDO will continue identify and to promote food borne illness outbreak investigation tools and best practices for posting on the Collaborative website. In the area of Active Managerial Control, AFDO will put on a series of train-the-trainer courses developed under the initial cooperative agreement for corporations, develop and disseminate guidance documents, infographics, and best practices through data from an industry survey, and create a training resource for smaller/regional food industry operators. We will continue to deliver the Root Cause Analysis course developed under the first cooperative agreement to lead food safety regulators and industry professionals and continue offering Environmental Sampling courses which were determined as a need from CDC After Action Reviews. AFDO pledges to share all information received and tools developed with the other associations in the Collaborative.